Diversity Supplement for: Engineered Asymmetric Hydrogel for Muscle Stem Cell Polarity and Fate Specification

PROJECT ABSTRACT
Fibro-adipogenic progenitors (FAPs) are muscle-resident mesenchymal stromal cells that support muscle
satellite cell (MuSC) function, including activation, proliferation, and differentiation. Unlike MuSCs, these cells
reside within the muscle interstitial space and thus communicate with MuSCs through paracrine factors. In
normal muscle regeneration, activated FAPs undergo apoptosis as the inflammation resolves and regeneration
proceeds. However, in chronic muscle injuries and diseases, activated FAPs persist and differentiate into either
myofibroblasts or adipocytes that drive fibrosis and fatty infiltration, respectively. However, to date, there is a
limited understanding of how the FAPs interact with their microenvironment to regulate their activation,
proliferation, and fate determination. In this Diversity Supplement application, we will determine the mechanistic
role by which FAPs respond to passive and active mechanical signals via mechanosensitive PIEZO1 ion channel.
This research strengthens and expands the scope of the parent R01 project by revealing how FAPs integrate
biophysical signals derived from their synthetic niche and provide additional means to control MuSC polarity and
cell divisions in the engineered asymmetric niche. Towards this goal, Aim 1 will determine how PIEZO1 regulates
FAPs activation, proliferation, and differentiation. Aim 2 will determine how PIEZO1 in FAPs regulates
extracellular matrix stiffness mechanosensing. Aim 3 will determine how PIEZO1 in FAPs regulates responsivity
to tensile loading and unloading. The outcomes of this research will advance the current knowledge of FAPs
biology, identify druggable targets to mitigate fibrosis and fatty infiltration in skeletal muscle injuries and diseases,
and inform the design of ex vivo FAPs manufacturing platform for expanding MuSCs and/or producing FAPs
secretome for acellular therapies.

Public health relevance
PROJECT NARRATIVE Fibro-adipogenic progenitors are muscle-resident mesenchymal stromal cells that support muscle satellite cell function through paracrine factors. To date, there is a limited understanding of how the FAPs interact with their microenvironment to regulate their function in pathophysiology. This project will determine the mechanisms by which muscle fibro-adipogenic progenitors respond to passive and active biomechanical signals.